Clinical Protocol and Data Management

Clinical Protocol and Data Management: Summary/Abstract
This section includes descriptions of the HDFCCC Clinical Protocol and Data Management (CPDM) functions
and Data and Safety Monitoring (DSM) functions. CPDM functions are provided by the Clinical Research
Support Office (CRSO), and DSM is provided by the Data and Safety Monitoring Committee (DSMC). The
development, review, implementation, conduct, monitoring, and reporting of all cancer clinical trials undertaken
in the HDFCCC are managed as centralized functions, requiring the coordination of CRSO and DSMC
activities with Protocol Review and Monitoring System (PRMS) activities. This coordination is enhanced by the
organization of the clinical research infrastructure, in which the activities of the PRMS, DSMC, and the CRSO
remain independent but are coordinated by the Cancer Center Clinical Research Oversight Committee
(CCCROC; see Director's Overview and Leadership, Planning and Evaluation for full description).